How retinal silencing restores synaptic strength in visual cortex of adult amblyopia

Amblyopia is a prevalent form of visual disability that arises during infancy and early
childhood when inputs to the visual cortex from the two eyes are poorly balanced (for
example, by misalignment of the eyes, asymmetric refraction, or blocked vision of one
eye). Characteristics of amblyopia are poor visual acuity in one eye, and an attendant
loss of depth perception. The need for improved treatments for amblyopia is widely
acknowledged.
Animal studies over the past 50 years have uncovered the pathophysiology of
amblyopia. It is well documented that temporary monocular deprivation alters the
strength of synapses in primary visual cortex that renders cortical neurons unresponsive
to stimulation of the deprived eye. However, much less is known about the mechanisms
that serve recovery from amblyopia. We recently discovered that temporary local
anesthesia of the retina sets in motion changes in the brain that enable complete
recovery from the effect of early life monocular deprivation. Our objectives are to
uncover the mechanism for how this recovery occurs, and to determine if this knowledge
can be translated into new and better treatments for amblyopia.

Public health relevance
Amblyopia is a prevalent form of visual disability that arises during infancy and early childhood. Using the principles of synaptic plasticity, novel strategies have been devised to promote recovery of vision at older ages than is possible using current standard of care. Understanding the underlying mechanism may lead to new treatments for amblyopia and other visual disorders.